Unconventional Sources of Peptides for Antigen Presentation

Unconventional sources of peptides for antigen presentation
Project Abstract
The long term goals of this project are to understand how the antigen processing pathway generates
peptide/MHC class I complexes (pMHC I) by cryptic translation. Numerous studies, from different
laboratories, have shown that naturally processed pMHC I on the surface of tumors, virally infected cells,
transfected or even normal cells arise from regions of mRNAs that were not expected to be translated.
The mechanism that allows cells to sample this cryptic source of antigenic precursors versus other
conventional sources are poorly understood. Moreover, the conditions that enhance presentation of cryptic
peptides in cells are not well defined.
Here we will test the hypotheses that (a) cryptic pMHC arise due to translation initiated by a distinct
and novel set of tRNAs and ribosomes, (b) expression of cryptic pMHC I is regulated in cells under stress,
and (c) the eIF2A translation initiation factor makes a key contribution to the cryptic pMHC I repertoire and
immunity.
We anticipate that an improved understanding of how cryptic pMHC I are generated will not only
provide a means to tap into a novel sources of antigenic peptides and new approaches to vaccine design
for intractable viruses and cancer, but will also yield new insights into protein translation and immune
surveillance mechanisms.

Public health relevance
We anticipate that this research will improve our understanding of why immune responses are directed to cryptic peptides as well as immunological and biological significance of cryptic translation.